Administrative Core

Summary: Administrative Core
IPCAVD Synthetic DNA launched and Adjuvanted Env immunogens for HIV
This IPCAVD will develop 2 plasmid products from concept to down selection in animals
support GMP production and assist the HVTN with IND submission for an HVTN clinical
trial to be initiated in year 5 of the program. The Administrative Core is responsible for overall
program performance providing administrative governance and oversight to ensure Program
goals are met. Outcomes will be achieved through active program management of administrative
and financial support, project monitoring and reporting, research compliance oversight, team
communications/meetings organization and facilitation, resource management, conflict
resolution, intellectual property management, support sample distribution. In these functions, the
AC will be responsible for overall program performance, personnel support, sample
distribution/coordination among the team, and for guiding the NHP animal studies. The Admin
Core will work with NIH/DAIDS and the HVTN - assembling a stellar SAB for yearly review to
advise the program. The SAB meeting guidance outcomes will be reviewed with DAIDS for
necessary programmatic adjustments to be implemented to keep the program goals on track. The
Admin Core will provide yearly written reports on progress for DAIDS program review and formal
feedback. The AC will arrange biweekly Project team Video calls for open data discussion and
time line review, monthly calls with NIH/DAIDS and the program PIs, inviting HVTN participation
and provide a quarterly update for HVTN. The Administrative Core will coordinate the NHP studies
activities between the Projects and the designated NHP site at Bioqual, with special attention
given to the NHP studies that are for product advancement and HVTN trial information. To
facilitate this mission the core imbeds an experienced industry project manager with significant
DNA product development experience, in the core for these activities (Dr. Smith - Inovio Project
3) to facilitate the primate work Bioqual and serve on the NSC. Dr. Patel will chair the IPCAVD
NHP working group which includes Dr. Weiner, Dr. Kulp, Dr. Shaw, Dr. Betts, Dr. Smith, and Dr.
Ferrari on a quarterly basis to review and facilitate the integration NHP studies under this program.
Minutes will be taken by Mr. Zaidi and distributed to the members. The Administrative core will
also facilitate publications of work accomplished with the team and report data presentations at
meetings of the team to DAIDS. Dr. Weiner is PI of the Admin Core, and its administration is
assisted by Dr. Kulp. In addition, Dr. Patel will form part of the conflict resolution committee.